2021 Dendrites: Molecules, Structure and Function Gordon Research Conference and Seminar

PROJECT SUMMARY
This proposal is for support of partial registration costs for speakers, discussion chairs and selected attendees
of the 2021 `Dendrites: Molecules, Structure and Function' Gordon Research Conference and associated
Graduate Research Seminar. This Gordon Research Conference reflects the growing understanding that
dendrites play a central role in neuronal computation. Thousands of synaptic inputs arrive at different locations
along a neuron's dendrites and that the subsequent integrative process ultimately determines that neuron's
output. Recent advances in molecular, electrophysiological, and imaging techniques have led to a new picture
of dendrites, and a deeper understanding of their computational role. Many complex mechanisms shape dendritic
structure, function, and connectivity. Further, dendrites can undergo plastic changes in structure and function
during development and learning, but also during neurodevelopmental and neurodegenerative disease.
Computational and theoretical approaches have further refined our views of dendrites and their unique role in
brain function. This Gordon Research Conference will bring together researchers whose latest findings help
clarify how the molecular and electrophysiological properties of dendrites enable them to perform complex
computations important for sensory-motor processing and higher cognitive function. The conference will be of
interest to researchers and students in neuroscience, as well as to anyone interested in normal and abnormal
brain function. There are three specific aims or goals associated with this conference: Specific Aim 1: To provide
a forum for the presentation and discussion of state-of-the-art research on dendrite structure and function in the
healthy brain and in disease. Specific Aim 2: To provide opportunities for engagement between investigators
at all career stages, from diverse backgrounds, a range of educational and research institutions, and from
disparate geographic locations. Specific Aim 3: To attract early career scientists to the dendrites field and
mentor their development. A Graduate Research Seminar (GRS) held prior to the main meeting will allow young
investigators to interact with their peers and present their work in a relaxed environment. The GRS will also
feature a professional development panel discussing careers in and out of academia.

Public health relevance
NARRATIVE Neurons in the mammalian brain have complex dendritic structures and nonlinear membrane properties, along with intricate spatial organization of synaptic inputs. These features confer significant computational and plasticity advantages for the neurons and for the network that they form. This Gordon Research Conference and Seminar will provide a forum for the presentation and discussion of state-of-the-art research on dendrite structure and function in the healthy brain and in disease, with the goal of fostering cross-disciplinary interactions and attracting young scientists to this important field.